Center for the Study of Symptom Science, Metabolomics and Multiple Chronic Conditions

Abstract: Administrative Core
The over-arching goal of the “Center for the Study of Symptom Science, Metabolomics and Multiple Chronic
Conditions (MCC)” is to strengthen the capacities of nurse scientists to conduct innovative translational
research using cutting-edge metabolomics and microbiomic technologies to reduce symptoms in individuals
with MCC. The research aims of the Center are to apply next-generation metabolomics technology and data
analytic strategies to stimulate discovery of the metabolites and metabolic pathways that are present in
individuals with MCC, focusing on metabolites and pathways that synergize across conditions and associate
with severe symptoms of fatigue, depression, or anxiety and their cluster, but are absent in individuals with
MCC with minimal or no symptoms. Metabolites and metabolic pathways associated with high symptom
severity will be evaluated in light of covariates such as sex as a biological variable, age, chronic stress and
discrimination, diet and medications. An exploratory aim will additionally investigate the composition of the gut
microbiome as a potential covariate to these symptoms. Our exploratory aim takes advantage of our School’s
strength in microbiome research and evidence linking the microbiome to these symptoms. The Administrative
Core will serve as a critical leadership for the Center and provide coordinated support for the work of its
members. The aims of the Administrative Core are to:
Aim 1. Establish and manage the infrastructure, strategic direction and plan of the Center, including
identifying new opportunities and collaborations for capacity building.
Aim 2. Provide administrative and financial oversights to three Cores and Center’s pilot projects and
enable pilot project investigators to develop a program of research.
Aim 3. Promote the dissemination of Center resources and activities and research findings related to the
science theme of the Center.
Aim 4. Implement formative and summative evaluation plans to assess the outputs, outcomes and impact
of the Center and execute efforts to promote sustainability of the Center.
The Administrative Core is structured based on the NINR Center Directors Logic Model for Center
sustainability and key concepts and processes of strategic management and takes advantage of the
exceptional resources available within the School of Nursing and across Emory University. The Administrative
Core brings together nationally and internationally known experts in the relevant areas of the Center’s scientific
focus to provide the necessary infrastructure to oversee Center activities and facilitate and strengthen
collaborative, interdisciplinary research and development of junior nurse investigators.